Chicago Asthma School-Directed Child-Centered Assessment and Dissemination of Evidence (CASCADE) Program

PROJECT ABSTRACT
Significant health disparities persist in childhood asthma prevalence and morbidity despite existing evidence-
based asthma guidelines that have been shown to improve outcomes. Schools are an integral partner in
asthma management. Prior literature has outlined various targeted school-based interventions with some
positive outcomes; however, these programs focus on individual components of the guidelines and take place
transiently without integration into school processes for sustainability. To more comprehensively impact
asthma care, schools have enacted policies to support guideline-based practices; however, implementation
falls short and thus these policies have not led to effective, systemic practices. Therefore, I aim to bridge the
gap in the implementation of asthma guidelines and policies by developing and evaluating a pragmatic, multi-
component school-directed, child-centered asthma program that builds upon existing targeted interventions
and is integrated in the school to foster sustainability. This innovative project contributes beyond existing
school-based programs by simultaneously and pragmatically implementing multiple components of the asthma
guidelines through school-wide systems and streamlined processes led by lay health workers. I have built a
strong foundation for this novel and important research by developing a strong partnership with a multi-campus
urban school network that serves a minority, low-income population and conducting preliminary research that
highlights the important gaps in asthma care. In this proposal, I will develop and evaluate an innovative multi-
component program in two elementary schools (Aim 1). First, I will pilot guideline-based intervention
components and determine feasibility and efficacy (1A). I will then utilize this data and existing literature about
school-based interventions to implement and evaluate a multi-component program (1B). Key outcomes will
focus on the patient (asthma control), organization (school attendance), and cost. In addition, I will determine
diverse stakeholder perspectives about the program components and the overall program as part of a pre-
implementation assessment to prepare for broader implementation and dissemination in a large, diverse urban
public school district (Aim 2).The results will be used for R01 studies that expand the application of the school-
directed, child-centered model to the large, diverse public school district in Chicago, compare its effectiveness
to other school-based asthma interventions, and conduct a full societal cost-effectiveness analysis. During this
career development award, I will work closely with my mentors and an expert advisory committee of leaders in
health disparities, asthma, community and school-based programs, implementation science, and statistical and
cost analyses. This award will allow me to obtain additional necessary training in advanced research methods
and data analysis, as well as implementation and dissemination research. The proposed research and training
will position me to become an independent investigator and national leader who integrates community-
engaged research with implementation science to advance patient outcomes and reduce asthma disparities.

Public health relevance
PROJECT NARRATIVE Research has shown that adherence to evidence-based asthma guidelines leads to improved outcomes, yet critical gaps remain in the implementation of these guidelines, particularly among minority and low-income youth. Schools represent a crucial point of intervention, as demonstrated by school-based asthma programs that have addressed individual components of the guidelines with promising results. This proposal aims to develop, implement, and evaluate a pragmatic, multi-component asthma program that builds upon existing targeted interventions to fully implement the asthma guidelines and integrate them in school practices to foster sustainability.